Apolipoprotein CIII inhibition in partial lipodystrophy

In the past fiscal year, all subjects have completed treatment on this study, and the study data set is being assembled. No preliminary analyses of results have been performed to date.